HSR&D Senior Research Career Scientist Award

This proposed Senior Research Career Scientist award is to support the activities of Dr. Kelli Allen, an
established Department of Veterans Affairs (VA) Health Services Research and Development (HSR&D)
investigator, allowing her to her expand her scientific, mentoring and service contributions. Dr. Allen’s
research focuses on improving care and outcomes for patients with chronic musculoskeletal (MSK) conditions,
particularly osteoarthritis. The majority of Dr. Allen’s research has been conducted in the VA healthcare
system. MSK conditions are among the most prevalent and disabling conditions among Veterans, who bear a
greater burden of these health problems compared with the general population. In addition, research by Dr.
Allen and others has shown that there are gaps in quality of care for MSK conditions, including underutilization
of first-line, evidence-based treatments such as physical therapy and behavioral interventions. To address
these important challenges, Dr. Allen’s research particularly focuses on conducting pragmatic and
effectiveness trials of behavioral and health services interventions for patients, particularly Veterans, with
chronic MSK conditions. The goal of these trials is to develop and test programs and delivery models that can
be implemented in the VA, as well as other healthcare systems, to improve care quality, efficiency and patient-
centered outcomes.
Dr. Allen has led eight randomized controlled trials of interventions for MSK conditions, as well as a
number of pilot and observational studies in this research area. Among trials Dr. Allen has led, intervention
approaches have included telephone-based patient programs (self-management, physical activity, weight
management, cognitive behavioral therapy for pain), a primary care provider-based approach to improve
osteoarthritis management, group-based physical therapy, internet-based exercise programs, and a stepped
care approach to increasing physical activity and function in patients with osteoarthritis. One example of a
health system impact resulting from Dr. Allen’s research is the local VA implementation of a group-based
physical therapy program for osteoarthritis, which was found to be as effective as individual physical therapy
but requires fewer resources and can improve access. Dr. Allen has also been a co-investigator on many MSK
studies, including five active trials of diverse care models and intervention approaches for treating osteoarthritis
and chronic low back pain. As a co-investigator, Dr. Allen’s contributions focus on methodologies for
conducting large pragmatic trials.
In addition to Dr. Allen’s research activities, she has contributed to many national and international
committees and leadership panels. Recent activities include service on VA HSR&D grant review panels, the
steering committee for HSR&D State of the Art Meeting on Non-Pharmacological Pain Management, and the
VA Pain Measures Work Group. She is also an Associate Editor for Osteoarthritis and Cartilage, a leading
orthopedic journal.
The protected time allowed by a VA HSR&D Senior Research Career Scientist award will allow Dr. Allen to
enhance her contributions to the VA HSR&D mission, with a focus on improving care for Veterans with chronic
MSK conditions, as well as enhancing the conduct of pragmatic trials in the VA. In addition to increasing her
overall participation in local and national VA committees, Dr. Allen’s proposed activities for the award period
include: 1) Leading a broad effort to understand heterogeneity of treatment effects in MSK conditions, 2)
Developing and leading a national work group to enhance and facilitate pragmatic trials in the VA and 3)
Increasing mentorship of junior investigators with expertise and interests in care models and quality for chronic
MSK conditions.

Public health relevance
The purpose of this award is to support the research, training and service activities of Dr. Kelli Allen, who is an experienced Department of Veterans Affairs investigator. Dr. Allen leads research studies that test different programs and health care approaches to see whether they help to improve outcomes like pain and function for Veterans who have musculoskeletal conditions such as osteoarthritis and low back pain. This research is important because musculoskeletal conditions are extremely common among Veterans and often lead to pain and disability. Veterans experience musculoskeletal conditions at higher rates than non-Veterans. Dr. Allen’s research will continue to study how we can best provide care for Veterans with chronic musculoskeletal conditions.